Work as a determinant of health: A pragmatic trial of enhanced cognitive behavioral therapy to bolster competitive work and wellness in veterans with serious mental illness (WORKWELL)

Project background: Work is a major social determinant of health. In people with serious mental illness
(SMI), work is associated with better wellbeing, physical and mental health, quality of life, and may
prevent the onset of disability. Among Veterans with SMI, work is a protective factor against suicide.
Most veterans with SMI are unemployed and suffer substantially worse health and recovery
across key domains. Despite quality VHA vocational services, such as supported employment (SE),
two-thirds or more of veterans who receive these services experience work dysfunction. A probable
explanation lies in unsolved cognitive and behavioral barriers, such as low work-related self-efficacy,
ineffective coping skills, little hope that work is attainable, poor work motivation and sense of self.
The Cognitive Behavioral Therapy for Work Success (CBTw) intervention was designed to
target these problems and augment VHA SE services to synergistically improve work, as well as health
and recovery, in Veterans with SMI. In an open trial pilot, CBTw was associated with significant
increases in hours worked and wages earned and the majority of CBTw participants became steady
workers. Veterans also experienced improvements in symptoms, recovery, and quality of life.
Project goals: Using Hybrid 1 RCT design, this project will test the effects of CBTw on competitive work
and health and recovery outcomes over a 9-month study period at 3 VA SE programs. Informed by the
RE-AIM framework, an implementation evaluation will examine the success of using SE staff to deliver
CBTw, barriers and facilitators to implementation, and strategies utilized.
Relevance to priorities: This project has high implementation potential and is responsive to the VHA
priority regarding Health Equity, as it will address work functioning, an under studied social determinant
of health. WORKWELL also holds promise to improve health and recovery outcomes among Veterans
with SMI, another HSR&D area of emphasis. Lastly, this study is consistent with the goal of finding
novel strategies toward suicide prevention among vulnerable Veteran groups, including those with SMI.
Objectives: Aim 1: Test the effects of CBTw + SE compared to a control of psychoeducation + SE on
work. Hypotheses: Participants in the CBTw+ SE arm will work significantly more total weeks in
competitive jobs (primary study outcome) and will be more likely to become steady workers.
Aim 2: Test the effects of CBTw + SE on health and recovery. Hypotheses: Participants in the CBTw +
SE arm will have greater improvements on subjective recovery and health-related quality of life, and
decreases in symptoms, suicidal ideation, and inpatient service utilization.
Aim 3: Guided by the RE-AIM implementation science framework, conduct an evaluation of the
implementation of CBTw, including examination of the feasibility of using SE staff to deliver CBTw, and
related barriers and facilitators. The objective is to spur future wide scale CBTw implementation.
Project Methods: WORKWELL is a pragmatic, Hybrid 1 design RCT. CBTw will be tested at 3 SE
sites—Roudebush VA Medical Center, the Edward J. Hines VA Medical Center, and the VA St. Louis
Health Care System. 276 unemployed Veterans with SMI will be randomly assigned to receive CBTw
plus SE or a control of psychoeducation plus SE. Outcomes including total weeks worked in
competitive jobs (primary), achievement of steady work, symptoms, recovery, health related quality
of life, suicidal ideation, and service utilization will be assessed at posttreatment (12 weeks), 6 months
(primary endpoint), and 9 months (to examine sustained effects). CBTw implementation planning,
training, and consultation will be provided. CBTw implementation (fidelity), barriers and facilitators to
implementation, and other RE-AIM elements will be examined using mixed methods.

Public health relevance
Vocational instability in Veterans with serious mental illness (SMI) is pervasive, costly, and harmful. Over 75% of Veterans with SMI are unemployed, resulting in economic difficulties and trouble meeting basic needs. Overall, among adults with depression, work dysfunction results in a 36 to 51 billion dollar loss annually. Unemployed Veterans with SMI also suffer major health consequences, including a more severe course of illness and poor recovery over time, leading to increased inpatient and emergency service use. The WORKWELL study will synergistically address these deficits in health, recovery, and work functioning by testing the Cognitive Behavioral Therapy for Work Success (CBTw) intervention. Using a pragmatic design, this project will address work as a major social determinant of health and close the health disparity gap among people with SMI. Further, through promotion of work and healthy thinking, CBTw holds promise to reduce risk of suicide among vulnerable veterans with SMI.